A New Pacing Approach for Cardiac Conditioning and Enhanced Cardioprotection

Significant advances in prevention and mitigation of cardiovascular disease have been made, but
related morbidity and mortality remain high. Cardiac conditioning is a therapeutic approach to induce
endogenous protective adaptive responses in the heart for counteracting myocardial loss. Identification of new,
widely applicable, practical, and effective strategies to induce cardiac conditioning continue to be a priority.
Exercise is one of the most powerful modifiers of cardiovascular risk, with proven benefits for both healthy and
diseased hearts. One key component of exercise is episodic heart rate (HR) acceleration interspersed with
periods of rest. The degree and pattern of HR acceleration informs the benefit of physical activity, with a HR
increase to 75-85% maximum predicted by age, for 75-150 min/wk, divided over 3-5 d/wk, being a typical
recommendation for promoting cardiovascular conditioning. Conversely, an impaired HR response to exercise
is associated with adverse clinical outcomes in healthy adults and those with heart disease. Furthermore, our
recently published findings indicate that an episodic exercise-similar envelope of HR acceleration can serve as
a trigger for myocardial conditioning and ischemic stress resistance. Specifically, in mice sham intervention
was compared to exercise-similar episodic HR acceleration, delivered by an atrial pacing protocol with
preserved atrioventricular and interventricular synchrony. The episodic exercise-similar pacing envelope
improved myocardial ischemic stress tolerance with an effect size similar to that afforded by treadmill exercise
or ischemic preconditioning. Hearts from paced mice displayed changes in Ca2+ handling, coupled with
changes in transcriptional and posttranslational remodeling associated with a cardioprotective paradigm.
In human subjects with already-implanted pacing devices for treatment cardiomyopathies with chronic,
medically refractory systolic heart failure, and left ventricular ejection fraction (EF) <=35%, the exercise-similar
pacing pattern, delivered through manual programming, was hemodynamically and symptomatically well-
tolerated. Furthermore, preliminary results in subjects who underwent pacing intervention 3 days/week over 4
weeks indicate increased 6-min walk distance, as well as trend towards improved EF, vs. sham intervention.
Building on these data, the proposed project will further delineate the mechanisms for myocardial
conditioning promoted by the exercise HR envelope using two synergistic but independent approaches: 1)
Study of wildtype and genetic mouse models to probe, dissect and validate molecular mechanisms underlying
cardioprotection driven by an exercise HR pattern, and 2) Leveraging the compatibility of the proposed
intervention with existing clinical pacing platforms to establish a mechanistic link between exercise’s HR
pattern and cardiac conditioning in human subjects with cardiomyopathies. If successful, the results will lay the
groundwork for expanded use of existing pacing hardware as a novel treatment to improve functional status
and quality of life, reduce the risk of cardiovascular events, and promote engagement in physical activities.

Public health relevance
Project Narrative Cardiac conditioning is a therapeutic approach to induce endogenous protective adaptive responses in the heart for counteracting myocardial loss and dysfunction to prevent cardiac mortality and morbidity. This project explores the role and mechanisms of the exercise-driven heart rate acceleration pattern on cardiac conditioning and the clinical utility of a novel cardiac pacing method to improve cardiac resistance to injury and improve outcomes in patients with cardiomyopathies.